Watson Phase I COBRE Admin Core

ADMINISTRATIVE CORE PROJECT SUMMARY / ABSTRACT
The Center of Biomedical Research Excellence in Multiscale Biomolecular Sensing will unite experts in biology,
biochemistry, chemistry, spectroscopy, materials science, and biomedical engineering to develop novel
mechanisms and tools for sensing of biochemical and biological processes that will directly impact a wide range
of human diseases. A strong Administrative Core is essential both to the function of the Center and for maximizing
its scientific impact. This Core will lead administrative and fiscal operations of the Center, as well as support the
scientific operations of the Research Projects and the Research Core. A diverse team of internationally
recognized, NIH-funded researchers with broad scientific expertise will collaborate to rigorously manage the
workload of the Center. Mentoring of the Research Projects Leads to ensure their success will be central to the
mission of the Center, including a mentor training program for the faculty mentors of the Research Projects
Leads. The Center will strive to continuously improve itself through rigorous, assessment and evaluation. To
accomplish our goals, we will:
Aim 1. Lead the Administrative, Fiscal, and Scientific Aspects of the Proposed COBRE.
Aim 2. Implement a Mentoring and Career Development Plan.
Aim 3. Expand Center Impact Through Development, Growth, and Retention of Faculty.
Aim 4. Assess Progress Towards Center Milestones Using Summative and Formative Evaluation.
Success of the Administrative Core will result in the growth of the Center and the expansion of the footprint of
biomolecular sensing at the University and in the State of Delaware.

Public health relevance
PROJECT NARRATIVE Project Narrative is not required in this component